Transforming Growth Factor - Beta Superfamily Signaling in Diabetes and Obesity

Imbalances in glucose and energy homeostasis are at the core of the worldwide epidemic of obesity and diabetes. We uncovered an important role of the TGF-beta/Smad3 signaling pathway in regulating glucose and energy homeostasis. Smad3-deficient mice are protected from diet-induced obesity and diabetes. Interestingly, the metabolic protection is accompanied by Smad3-deficient white adipose tissue acquiring the bioenergetic and gene expression profile of brown fat/skeletal muscle. Smad3-deficient adipocytes demonstrate a marked increase in mitochondrial biogenesis, with a corresponding increase in basal respiration, and Smad3 acts as a repressor of PGC-1alpha expression. We observe significant correlation between TGF-beta1 levels and adiposity in rodents and humans. Further, systemic blockade of TGF-beta signaling protects mice from obesity, diabetes, and hepatic steatosis. We have recently shown that TGF-beta regulates the myokine irisin in the context of exercise. Together, these results demonstrate that TGF-beta signaling regulates glucose tolerance and energy homeostasis and suggest that modulation of TGF-beta activity might be an effective treatment strategy for obesity and diabetes. We continue to examine the mechanistic underpinnings of the above mentioned observations as they related to the role of TGF-beta family signaling in diabetes and obesity pathogenesis. We have reecntly uncovered a role for TGF-beta receptor signaling in regulation of hepatic gluconeogenesis and beige adipogenesis.